GROWTH CURVES OF ADULT INTELLIGENCE BY TIME LAG TESTING

Our previous research on the Wechsler Adult Intelligence Scale (WAIS; NIA grants AG02695, and AG 07407) has produced: (1) a large-scale data base of WAIS information useful for aging research, (2) some novel structural equation models appropriate for aging research, (3) some complex results about the measurement basis of the WAIS, and (4) some complex results about the Growth Curves of Intellectual Ability. One clear result is that the WAIS provides good measures of Crystallized Intelligence, but it does nor provide a good measurement of Fluid Intelligence. Another result is that Growth and Decline processes, are not a simple function of age, but mst be understood in terms of other individual characteristics as well. In this continuation proposal we provide an experimental and efficient plan to unravel some of this complexity in adult abilities research. We propose to test a highly selected set of adults who have already been tested before on a wider battery of ability measures. We will recruit and test N=300 adults from our available files who have (1) been tested before on the WAIS or the Woodcock-Johnson (WJ) tests of intellectual ability (2) are between the ages of 19 and 80 years of age, (3) are spread out in geographical areas of the USA, and (4) who have a specific time lag between their tests (i.e., 2 years to 34 years). We also propose to use a more extensive battery of ability tests, including: (5) the WAIS, (6) the Woodcock-Johnson Revised (WJ-R) test of abilities, (7) Horn's additional markers of the main ability factors, and (8) a demographic questionnaire. This is a continuation of our previous work on several ways. First, we developed the questions from substantive issues about the aging of abilities. Second, we have developed the mathematical and statistical models for growth and change y trying to deal with the massive set of complex WAIS data. Third, we have already gathered longitudinal retest data on the Bradway Longitudinal Data and the National Growth and Change Study (NGCS) samples. In contrast to our prior work, these retested subjects and variables are chosen by a structural experimental design that will allow us to use latent variable structural equation models to unravel (1) the effects of retest from growth, (2) the factors of measurement from the factors of growth, and (3) the direct from the indirect aging effects on these factors.